2024 Santa Cruz Developmental Biology Meeting

PROJECT SUMMARY
This grant application seeks funding for the 2024 Santa Cruz Developmental Biology Meeting, which will be
held on the campus of University of California at Santa Cruz from August 23-27, 2024.
This meeting is a biennial, grass-roots meeting organized by and for the scientific community working at the
cutting edge of developmental biology. The Santa Cruz meeting, which has run continuously since 1992, oc-
cupies a unique niche by combining international reputation with a relatively small size (~150 attendees) and a
wholly new line-up of invited speakers at each gathering. As detailed in our application, we have planned for
considerable participation by graduate students and postdocs by including short talks, posters, two work-
shops aimed at career issues, and a career-perspective talk from a prominent scientist whose storied career
pathway epitomizes the multi-disciplinary nature of developmental biology. The meeting format is based
around single-platform sessions and three non-overlapping poster sessions so that all participants are
engaged with the same topic and activity for the entirety of the meeting.
The theme for 2024, “Unifying Principles of Organismal Development”, seeks to highlight common themes as
well as top challenges facing the field, both conceptual and technical, as we seek fresh insights into the
complex mechanisms underlying organismal development, tissue renewal, and the evolution of new forms.
One chief goal of this meeting will be to bring together diverse researchers in an informal setting to highlight
work across a broad spectrum of relevant systems, fostering cross-interaction between research fields and
synthesis of new ideas. A second major goal will be to provide a forum for a diverse group of undergraduates,
graduate students, and postdoctoral fellows to engage with and present their work to leaders in the field
through talks, poster sessions, and informal discussions fostered by an isolated and relaxed campus setting.
Along with a distinguished panel of four senior keynote speakers, the seven platform sessions will feature
scientists working with a wide range of model organisms to address fundamental and emerging questions that
form the basis for modern developmental research. Topics include: Cell-cell Communication, Theory and
Modeling in Development, Active Matter and Mechanics, Convergent and Divergent Morphogenesis, Cellular
Transitions and Plasticity, Information Processing & Gene Regulatory Networks, and New Technologies and
Synthetic Approaches. The discussion that will ensue among the conferees will enhance our inclusive,
multidisciplinary developmental biology community, stimulate new ideas, and accelerate basic developmental
research and progress toward clinically relevant applications.

Public health relevance
PROJECT NARRATIVE Research in developmental biology has made many fundamental contributions to our understanding of con- genital disease, stem cell biology, oncology, and regenerative medicine. Elucidating the genetic, molecular, and cellular control of developmental processes will help us decipher the logic of multicellular life, illuminate causes of birth defects, and ultimately lead to new techniques for diagnosis and treatment of human disease. The 2024 Santa Cruz Developmental Biology meeting will bring together experts working on fundamental de- velopmental mechanisms to stimulate new research directions and accelerate discovery in this dynamic and rapidly evolving field.